Elucidating the Role of Endocytosis Via the Cytostome in the Life Cycle of Trypanosoma cruzi

PROJECT SUMMARY
The etiological agent of Chagas disease, Trypanosoma cruzi, is an obligate intracellular parasite that infects an
estimated 10 million people in the Americas, with an at-risk population of 70 million. Despite its recognition as
the highest impact parasitic infection of the Americas, Chagas disease remains underreported, understudied
and underfunded. Basic research into the biology of T. cruzi has previously been hindered by a lack of efficient
genetic tools, but the advent of CRISPR/Cas9 gene editing technology has cleared the way for more in-depth
molecular analyses. Among the human infecting parasitic trypanosomatids, T. cruzi is extremely unique for a
number of reasons: it develops into its infectious form in the hindgut of insects, is transmitted to its mammalian
host via the feces of its insect vector, lives directly in the cytosol of its mammalian host cell and utilizes an
ancient feeding organelle to endocytose extracellular material in a manner much like its bacterivorous free-
living relatives. This endocytic structure is composed of a long tubular invagination (cytopharynx) starting at a
surface plasma membrane pore (cytostome) which we refer to here as the cytostome/cytopharynx complex or
SPC. The SPC is a highly dynamic organelle that is present and functional only in the replicating forms of the
parasite and disassembles during the transition to its infectious stages. Until recently the SPC had only been
examined using electron tomography techniques and had resisted molecular analysis as the protein
components comprising it remained elusive. Our initial published work described the first proteins known to be
targeted to the SPC and was followed by the identification of a family of SPC targeted myosin motors that we
show contribute directly to the endocytic process. Recently, however, we have identified an essential myosin
regulatory component of the SPC (MyAP1), a knockout of which resulted in parasites that are completely
devoid of measurable endocytosis and who are defective in their ability to scavenge host lipids. Although viable
in culture, we have also demonstrated through infections of the insect vector (R. prolixus) that endocytosis is
critical for the parasite to be able to establish a robust infection and colonize the insect hindgut, a necessary
step for effective transmission to its mammalian host. Completion of this study will allow us to continue to
elucidate the molecular machinery responsible for the formation and function of the SPC as well as give insight
into why it is that T. cruzi retained this ancient mode of nutrient uptake. Our endocytic-null mutant also gives us
the unique opportunity to finally examine the “endocytome” of this parasite. Although not limited to lipids, we
are excited by preliminary data allowing us for the first time to now distinguish which lipids are actively being
scavenged through endocytosis from those which the parasite is able to endogenously produce for itself. The
goal for this proposal is ultimately to give greater insight into parasite pathways essential for vector
transmission as well as provide a window into the biosynthetic pathways that are actively present and
necessary for parasite viability.

Public health relevance
PROJECT NARRATIVE Trypanosoma cruzi is an obligate intracellular parasite of the kinetoplastid family that infects upwards of 10 million people in the Americas with approximately 30% developing life-threatening clinical disease. As part of its basic nutrient acquisition strategy, T. cruzi directly ingests extracellular material via an enigmatic endocytic structure known as the cytostome/cytopharynx complex (SPC) and this study seeks to characterize the molecular machinery responsible for constructing, powering and regulating this endocytic organelle. Our work seeks to address a longstanding question regarding the primary role of the SPC in the parasite life cycle as it serves as one of the major points of contact in the host-pathogen interface during infection.